Biomedical 600 MHz High Field MR Spectroscopy and Imaging Magnet Upgrade

The 14T high-field vertical-bore NMR spectrometer and microimager has been a central facility for our institution
across nearly four decades, making contributions to biomedical research in many fields including MR contrast
agent development, bone mineral developmental biology, tissue pathology, biomaterials, cancer, dental
implantology, metabolomics, aging, Alzheimer’s, cardiology, and others. The pioneering first demonstration of
the use of high resolution magic angle spinning (HRMAS) in NMR spectroscopy for tissue pathology was carried
out in this facility. Over the years it has evolved from a 9.4T/400 MHz instrument to a 14T/600 MHz instrument,
with several console and probe upgrades. It has supported many millions of dollars of funded grants, and played
a key role in the training of numerous students, fellows and faculty. It is one of the facilities that makes MGH
unique in hospital-based magnetic resonance research.
In addition to the existing R01s held by the current users, new projects that would be supported include the
neurophysiological basis of circuit-specific laminar resting-state functional MRI; commensal redox metabolism
in C. diff. infection prevention; and vascular calcification in atherosclerosis and valvular disease.
The magnet of this equipment has been in operation for over 21 years without being shut down for maintenance,
longer than most. Its nominal liquid helium consumption rate, although state of the art at the time of purchase, is
now considered excessive. Recently, the magnet has exhibited a very high consumption rate, indicative of the
need for maintenance. Although we are proceeding with the maintenance, the extraordinary cost of helium at its
specified consumption rate is unsustainable, and will become even more so as time progresses. The magnet
manufacturer is no longer in business, making maintenance increasingly difficult.
The only viable solution is a replacement of the magnet, by far the most expensive and central component of the
system. This would insure another two decades of operation, and the ability to get repair parts from or have it
serviced by, a stable, global company, Bruker BioSpin. Most importantly, it would permit a dramatic factor of four
reduction in helium consumption, with a concomitant reduction in operating cost.
The purpose of this grant is to replace the old 14T magnet with a modern Bruker 14T magnet.

Public health relevance
This project upgrades an aging, until recently highly productive, magnet for an NMR/MRI research instrument with a new magnet that is expected to provide another two decades of productivity. Research on this instrument has encompassed metabolic bone disease, cancer, Alzheimer’s disease, biomaterials, and many other biomedical fields. The upgrade will permit the continuance of these research programs, and enable several new areas such as infectious disease control.